Novel training environment to normalize altered finger force direction post stroke

Estimated 15,000 Veterans suffer a stroke each year. Stroke is a leading cause of long-term disability in the US.
New strokes cost an estimated $111 million for acute inpatient care, $75 million for post-acute inpatient care,
and $88 million for follow-up care in the first six months post-stroke in VHA. Yet, more than two thirds of stroke
survivors have persistent hand impairment that significantly diminishes their abilities to perform activities of daily
living. Dexterous manipulation of objects, such as tools, dishes, and smart phones, require not only proper hand
movement, but also proper force control. Not only movement, but also control of forces from fingers has been
shown to be profoundly impaired following stroke, resulting in the object being mishandled, or not handled at all,
and failure at task execution. Motor control literature shows that finger movement and force control involve two
independent neural controls, and therefore must be independently rehabilitated. However, conventional upper
extremity therapy focuses on movement control exclusively and does not address hand force control. This gap
in treatment is due to a lack of tools to provide explicit feedback on patients’ volitional finger force control. To
address this gap, a novel force training tool has been developed. This tool enables stroke survivors to practice
volitional finger force generation in three-dimension (3D) with explicit feedback on directional control, per best
known clinical motor learning strategy. Preliminary testing of this 3D force training showed significant
improvement in hand function (assessed by the Action Research Arm and Box and Block Tests, ARAT and BBT)
in stroke survivors with severe hand impairment. The objective of this project is to determine if 3D finger force
training is an effective tool in restoring hand function post stroke. Sixty Veterans with stroke with moderate to
severe hand impairment with palpable volitional grip force will be randomly be assigned to either the experimental
or control group, stratified by impairment level. Both groups will undergo 3 1-hr training sessions per week for 6 weeks.
The experimental group will receive explicit feedback in 3D force, whereas the control group will receive feedback in
1D only on a computer screen. This control condition is analogous to simple squeeze ball repetitions. Training will
progress by increasing influence of flexion synergy by varying posture requirements and increasing force level,
introducing feedback delay, and incorporating unilateral/bilateral activity. Evaluation will occur at baseline, every 2
weeks during 6-week intervention, and at 1-month follow-up. Aim 1: Determine the effect of 3D finger force training
on behavioral hand function. Hypothesis: Hand function will improve more in the experimental group than the control
group. Hand function will be assessed using ARAT, BBT, and Stroke Impact Scale. Meaningfulness of the intervention
will be assessed via qualitative interviews. Aim 2: Determine the effect of 3D finger force training on finger force
direction control. Hypothesis: The experimental group will achieve greater ability to direct finger force than control
after the training. The ability to direct finger force will be quantified as angular deviation of volitional finger force from
the target direction. Aim 3: Determine the biomechanical mechanisms underlying improvement in force direction
control. Hypothesis: The training results in improved muscular coordination. Improved muscular coordination will be
assessed by expansion of the attainable muscle activation patterns, increased motor complexity, similarity between
the paretic vs. nonparetic synergy structures, and reduced abnormal flexion synergy during
reach/grasp/transport/release. Hand-arm coordination will also be assessed. A custom OpenSim finger model will be
used to explain the direct biomechanical mechanism by which changes in muscular coordination leads to enhanced
finger force direction. Impact: This research will provide a treatment for force control, thereby addressing the unmet
need in the current rehabilitation exclusively focused on movement practice. This research will also determine the
underlying biomechanical mechanisms as well as the training’s impact on functional use of the hand. As a result,
this research is expected to enhance hand function, thus increasing independence and quality of life for Veterans
with stroke.

Public health relevance
This research is relevant for Veterans, as stroke is one of the leading causes of long-term disability in Veterans. An estimated 15,000 Veterans suffer a stroke each year. A novel rehabilitation treatment option developed as a result of this research has the potential to reduce the consequences of stroke for Veterans. Therefore, the proposed research is expected to contribute to providing Veterans with better post-stroke rehabilitation care with improved performance for activities of daily living.